COVID-19 Administrative Supplement to K01: Adapting, Pilot Testing a Behavioral Intervention to Incorporate Advances in HIV Prevention for Black Young MSM in Alabama

PROJECT SUMMARY
This application is for an administrative supplement to a current NIMH-supported K01 career development award
that was severely affected by the COVID-19 pandemic. My 5-year K01 began in May 2019, and less than a year
into the award, COVID-19 was declared a global emergency; all human subjects research and travel was halted.
The approximately three years of the pandemic occurred in the prime years of my K01 career development
award affecting both training objective and specific aim completion.
The overall goal of the original 5-year Mentored Research Scientist Development K01-Award is to support Henna
Budhwani, PhD, MPH become an independent investigator in the field of HIV prevention. The proposed project
seeks to address the HIV crisis in Alabama, where rates of undiagnosed HIV in Black young men who have sex
with men (YMSM, 18-29 years) exceed 20%. Four training objectives are proposed that are in lockstep with three
specific aims. Objective 1 includes an intensive training and mentoring plan in social theory. Objective 2 includes
in-depth training on qualitative research methods including how to conduct focus groups, in-depth interviews,
and qualitative data analysis. Aim 1, which will be conducted after Objective 2, is to elucidate experiences,
beliefs, and predictors related to delivery and utilization of HIV testing and prevention services by Black YMSM
using qualitative research methods, namely in-depth interviews with HIV outreach staff, focus groups with Black
YMSM, and in-depth interviews with members of key sub-groups to inform the adaptation of the Brothers Saving
Brothers (BSB) intervention. Objective 3 includes didactic and hands-on training on how to scientifically adapt
HIV behavioral interventions using validated frameworks, such as intervention mapping. Aim 2 is to adapt the
BSB intervention to include rapid testing and PrEP, to address structural barriers, and to be acceptable to black
YMSM in Alabama. Objective 4 includes comprehensive training and mentoring in the field of implementation
science. Aim 3, which concludes the proposed research study and K01 project, is to conduct a hybrid type 1
effectiveness-implementation pilot study of the adapted intervention. This rigorous project includes intensive
training at the candidate's home university and from other prominent institutions that offer very specific training
not found at UAB; comprehensive mentoring from senior HIV researchers; and a thoughtful research strategy
that addresses significant threats, high rates of undiagnosed HIV and insufficient engagement with HIV
prevention services, including PrEP, in Black YMSM in Alabama. The combination of the proposed mentoring
and training with study findings will culminate in the candidate's attainment of independence and development
of a full-scale implementation science-informed R01 proposal to test the new adapted intervention.

Public health relevance
PROJECT SUMMARY This research has the potential to make important contributions toward addressing some of the most significant and current public health challenges in the United States, namely high rates of HIV infection and HIV-related morbidity and mortality among Black young men who have sex with men. This study will do so by adapting a behavioral intervention, Brothers Saving Brothers, to include two HIV prevention tools (community-based rapid testing and pre-exposure prophylaxis), include sociostructural supports, and for delivery in a new environment (Alabama), then testing the adapted mHealth intervention employing an implementation science hybrid type 1 effectiveness-implementation trial design. Results of this study, jointly with the formal training and mentoring the candidate will receive through this K01-Award, will prepare her to develop a robust R01 proposal to conduct a full-scale implementation science randomized controlled trial of the adapted intervention across the South.